Multidisciplinary Training Program in Lung Disease

This application is a competitive renewal of the present Multidisciplinary Training Program
in Lung Disease (HL07749), which has been continuously funded since 1993. The goal of the
program is produce outstanding biomedical scientists who investigate the manifestations,
mechanisms, prevention, and treatment of pulmonary disorders. The program proposes to
support 12 postdoctoral fellows (M.D., Ph.D., and M.D./PhD.) per year. The investigative
approaches available to trainees include disciplines applicable at the molecular, cellular, tissue,
organ, whole animal and clinical population levels. The program is truly multidisciplinary, utilizing
faculty trainers from the Medical School, School of Public Health, the College of Pharmacy, and
the College of Engineering at the University of Michigan. A close relationship between a primary
mentor and a co-mentor(s) with the trainee is the foundation of the training experience. This
research experience is supplemented by a core group of lectures, workshops, core conferences,
and training in responsible research conduct, career planning, communication skills, and grant
writing. Emphasis is placed on personal instruction specifically designed for individual trainees.
Faculty and core lectures have been added to further solidify the disciplines of bioinformatics,
genetics/epigenetics, metabolomics, and the microbiome. Emerging areas of growth include host-
microbe interactions, transplantation biology, regenerative medicine, precision medicine, data
science, health services research and multi-institutional disease-specific clinical networks for
research. Postdoctoral trainees can acquire Master's Degrees in Clinical Research Design and
Statistical Analysis from the School of Public Health or health services research through the
National Clinical Scholars Program in Health and Healthcare Research. A broad range of
research topics is available to trainees including the pathobiology of acute and chronic lung disease,
host defense mechanisms, progenitor cell biology, bioinformatics, long-term outcomes in lung
disease and critical illness, physician decision making, cost/benefit analysis, application of medical
technology and implementation science. Fellows and mentors are reviewed by a committee that
monitors the training and career development of fellows. Eight underrepresented minorities have
completed our training program over the past 10 years. Ninety percent of graduates trained in the
past 15 years are in academic or industry positions, indicative of the program's success.

Public health relevance
The University of Michigan Multidisciplinary Training Program in Lung Disease provides research training for M.D. and Ph.D. scientists in both laboratory-based and clinical studies. The purpose of this training is to produce outstanding biomedical scientists who investigate the manifestations, mechanisms, prevention, and treatment of lung disease.